Voice Rest Adherence after Phonomicrosurgery

PROJECT SUMMARY/ABSTRACT
Title: Voice Rest Adherence after Phonomicrosurgery
The goal of this proposal is to examine adherence to post-surgical voice rest and the factors that affect
it. Voice rest is an essential component of rehabilitation after phonomicrosurgery for benign lesions, and is
thought to allow the vocal folds to heal and minimize scar tissue. There are currently no standards or
guidelines for duration and type of voice rest prescribed. Current recommendations are based primarily on
clinical experience and vary by physician, speech pathologist and clinical setting. Estimation of adherence to
the prescribed recommendation is based on patient reports at the end of the voice rest period and can be
highly variable and subjective. A small number of studies have shown poor levels of adherence to voice rest.
This non-adherence has been one of the primary obstacles to accurately measuring surgical and voice rest
outcomes and, creating standardized protocols for voice rest. There is also no information on factors that affect
adherence such as barriers and supports, impact on quality of life, personality etc.
The primary aims of this study are to measure subjective and objective adherence for two types of
voice rest (complete voice rest (CVR) and relative voice rest (RVR)) immediately after phonosurgery and,
predictors and factors associated with level of adherence. In the absence of specific guidelines for both voice
rest types, adherence will be indicated by amount of voice use on voice rest. This will be a randomized
controlled trial on fifty participants undergoing phonosurgery. Aim 1 of this study will compare patient-
perceived adherence using patient reports to estimated voice use measured objectively by a vocal dosimeter
for the 7-day voice rest period. These two measures of adherence will be compared within and between the
CVR and RVR groups. Aim 2 will identify voice rest factors associated with high or low levels of adherence.
Pre-operative factors include demographic information, scores on auditory-perceptual and patient ratings of
voice, motivation, level of talkativeness, personality and, perceived control. After completing 7 days of VR, data
will be obtained on impact on quality of life, alternate modes of communication used, economic impact,
supports and barriers. These factors will be compared between CVR and RVR and also as predictors of level
of adherence.
Data from this study will be useful on multiple levels. It will provide empirical data on adherence
differences between the two types of voice rests recommended and the difference between patient perception
and measured adherence. In addition, clinicians can tailor their treatment to maximize post-surgical outcome if
they can proactively identify predictors of poor adherence and modify their voice rest recommendations,
increase patient education pre-operatively or include a period of trial therapy when feasible. The inclusion of
adherence in the decision making process for voice rest recommendations is critical as we work towards
developing guidelines for post-surgical voice recommendations.

Public health relevance
PROJECT NARRATIVE Voice rest is critical to post-surgical tissue repair and adherence to voice rest recommendations is integral to its success. This study will measure perceived and actual adherence to two types of post-surgical voice rest and the factors impacting these levels of adherence. The results from this study will provide insight into the feasibility of following voice rest recommendations and direct clinicians into tailoring these recommendations to fit the needs of the patients.